EFFECT OF BROMOCRIPTINE ON GLUCOSE AND LIPID METABOLISM IN DIABETICS

This study is designed to determine whether the improvement in glucose tolerance is dependent upon weight loss and altered fat distribution, or represents an intrinsic alteration in insulin sensitivity.